Structure-based Bioengineering of Wnt Surrogates for Intestinal Stem Cell Biology and Therapy

ABSTRACT/SUMMARY
Wnt proteins are phylogenetically conserved, secreted glycoproteins that regulate cell-cell communication
during development and adult tissue homeostasis. Wnt binding to both Frizzled, which has structural
similarities to G-protein coupled receptors, and to the co-receptors Lrp5/6, initiates canonical (i.e. Wnt/b-
catenin) signaling, representing the most widely studied type of Wnt signaling. We and others demonstrated
that the intestinal epithelium is an archetypal canonical Wnt/b-catenin-dependent tissue, with a final common
phenotype of loss of intestinal crypts – and crucially – loss of Lgr5+ intestinal stem cells (ISC) uniformly
apparent upon by inhibition of Wnt ligands, their production, receptors or signaling. Because of this critical
role in the intestine and other stem cell compartments, the Wnt signaling axis is an important therapeutic
target, but unfavorable biochemical properties have impeded the use of Wnt as a regenerative drug. We
determined the first binary crystal structure of a Wnt in complex with a Frizzled ligand binding domain (CRD)—
a breakthrough that offered diverse insights into Wnt function. This revealed the molecular basis for Wnt/Fz
cross-reactivity, and elucidated the Wnt lipidation site and its essential role in Fz binding (Science, 2012).
This application exploits a synergistic collaboration between Chris Garcia and Calvin Kuo at
Stanford (Multi-PIs) to molecularly characterize Wnt/receptor interactions through biophysical imaging
approaches, thus enabling the structure-based protein engineering of artificial bioengineered Wnt
analogs which are directly applied to mechanistic and therapeutic investigation of the intestinal
epithelium and Lgr5+ ISC. Aim 1 continues our structural efforts to image the entire Wnt/Frizzled/Lrp6 ternary
transmembrane complex by X-ray crystallography and cryo-Electron Microscopy, building on preliminary
successes in expressing and purifying this multimolecular assembly. Aim 2 focuses on a potentially
transformative new discovery we have made that overcomes two major obstacles for translation of Wnts into
therapeutics: 1- difficulty of expressing natural Wnts as recombinant proteins due to their lipidation and 2- Fz
cross-reactivity. We have developed water-soluble, Fz-specific surrogate Wnt agonists that mimic all aspects
of Wnt activity but as an easily expressed non-lipidated recombinant protein. These engineered surrogate Wnt
agonists are not only biochemically tractable gain- and loss-of-function probes for basic Wnt signaling
mechanisms, but offer a new strategy for exploiting the Wnt signaling axis in regenerative medicine and will be
structurally optimized in Aim 2 for specific activity, Fz specificity and intestinal organoid growth. Lastly, Aim 3
explores the in vivo potential of these bioengineered surrogates for support of Lgr5+ intestinal stem cells,
mitigation of intestinal radiation damage and augmented transplantation of human intestinal organoids.
Collectively, this proposal pursues basic molecular insights into Wnt structure and signal initiation mechanisms,
and applies this information to practical problems in Wnt research and intestinal biology.
!

Public health relevance
Wnts are secreted growth factors critical for embryonic development and adult tissue regeneration, principally acting through Frizzled receptors, in concert with a variety of other receptors. The Wnt signaling axis represents a new therapeutic frontier for regenerative medicine. We are imaging Wnt-receptor signaling complexes using biophysical methods to understand the mechanisms that initiate the extremely complex biological functions of Wnts, and using this information to engineer artificial Wnt agonists as a new strategy to harness the powerful actions of native Wnts for therapeutic purposes and in intestinal stem cell biology.